Patient Decision Making about Breast Reconstruction after Mastectomy

DESCRIPTION (provided by applicant): Breast reconstruction after mastectomy is an important treatment option for the many thousands of women who undergo mastectomy each year. Its insurance coverage is mandated by federal law. Many women who want reconstruction, particularly women from racial and ethnic minorities, never receive it, and some women who undergo reconstruction regret having it, raising concern about the quality of decisions about the procedure. Little is known about the quality of breast reconstruction decisions, defined as the extent to which decisions are informed and concordant with patients' preferences. A lack of reliable methods for evaluating preference concordance has resulted in a paucity of research in this area. Deciding about breast reconstruction requires a patient to predict how she would feel after the procedure, a process called affective forecasting. Extensive psychological research has shown that people have difficulty making accurate predictions about how they will feel, tending to overestimate the effects of disease and treatments on their well- being and to underestimate their ability to adapt to change and the effects of other aspects of their lives. Despite the importance of affective forecasting to decisions about breast reconstruction, no research has examined this aspect of those decisions. We propose to conduct a pilot cohort study of breast cancer patients undergoing mastectomy, with or without reconstruction with the following specific aims: Aim 1: To evaluate the quality of decisions about breast reconstruction by assessing patient knowledge, concordance between preferences and treatment, and decision making processes; Aim 2: To assess the accuracy of patients' preoperative predictions about their post-operative body image and well-being and the association between prediction accuracy and satisfaction with decisions; and Aim 3: To assess the effects of breast reconstruction on quality of life and body image and the potential modification of these effects by preference concordance. This study is innovative in its use of a validated measure of knowledge that is specific to reconstruction, its use of a technique derived from marketing research called conjoint analysis to assess preference concordance, its focus on affective forecasting, and its prospective assessment of decisions. Our findings will inform a subsequent R01 to conduct a multi-site cohort study of decision making and outcomes of breast reconstruction. We believe this line of investigation will lead to more appropriate use of reconstruction and more patients achieving the outcomes they value. The candidate is a plastic and reconstructive surgeon with education and experience in health policy whose long-term goal is to improve the quality of surgical treatments for cancer. The specific objectives of this career development award are 1) To obtain education in psycho- oncology, outcomes research, and psychology of decisions; 2) to obtain skills in quality of life measurement, patient interviewing, preference elicitation, assessment of affective forecasting errors, enrollment and retention of incident cancer patients, and analysis of longitudinal observational data; 3) to evaluate the patient-reported outcomes of breast reconstruction and the role of decision making processes in those outcomes, in preparation for a multi-site cohort study; and 4) to develop the expertise, pilot data, and publication record necessary to be an independent investigator. This K07 career development award would position the candidate to become a leader in the decision sciences and clinical effectiveness research.

Public health relevance
PROJECT NARRATIVE Deciding whether or not to have breast reconstruction after mastectomy is highly challenging for many patients. This study will examine patients' decisions about reconstruction and the effects of reconstruction on quality of life and body image. This research will eventually lead to more patients receiving the treatments they prefer and ultimately to better quality of life for women with breast cancer. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Breast reconstruction is an important treatment option for the many thousands of women who undergo mastectomy each year. Most women who have a mastectomy are candidates for reconstruction, and insurance coverage for reconstruction is required by federal and state law. Despite this strong mandate, many women who want breast reconstruction never have it, and some women who have reconstruction regret it. Overall, how patients make decisions about this important procedure remains unclear. Two key elements of breast reconstruction decisions, the quality of decisions and the role of affective forecasting errors, warrant further study. Because the decision about reconstruction is preference-sensitive, the quality of the decision is defined by the extent to which it is informed and concordant with preferences. Little is known, however, about patient knowledge or preferences about reconstruction. Reconstruction decisions also depend heavily on patients predicting how they would feel with and without reconstruction, a process called affective forecasting. Unfortunately, people frequently make affective forecasting errors, tending to overestimate the impact of treatments on their well-being, underestimate their ability to adapt to change, and neglect the importance of other aspects of their lives for their well-being. The significance of affective forecasting errors in decisions about reconstruction is not known. We propose to conduct a pilot cohort study of women undergoing mastectomy, with or without reconstruction, in which we evaluate the quality of patient decisions, assess predictions about future well-being, and evaluate quality of life and body image before and after surgery. This study is part of a career development program that will position the investigator for an independent career in the decision sciences and clinical effectiveness research. It will lay the groundwork for a multi-site cohort study of decision making and outcomes of breast reconstruction, which would inform interventions to facilitate the appropriate use of breast reconstruction. The overall hypothesis of this work is that patients whose treatment is concordant with their informed preferences, and patients who can make accurate predictions about their well-being, will experience better patient-reported outcomes of mastectomy alone or mastectomy with reconstruction. Aim 1: To evaluate the quality of decisions about breast reconstruction by assessing patient knowledge, concordance between preferences and treatment, and decision making processes. We will enroll patients undergoing mastectomy at the University of North Carolina. We will measure preoperative knowledge about reconstruction, elicit preferences using conjoint analysis, and measure patients' report of decision making processes. Hypothesis 1: Knowledge and preference concordance will be low (overall knowledge less than 75%, preference concordance less than 75%). Specific skills to be obtained include enrollment of incident cancer patients and preference elicitation using conjoint analysis. Aim 2: To assess the accuracy of patients' preoperative predictions about their post-operative body image and well-being and the association between prediction accuracy and satisfaction with decisions. Prior to surgery, we will ask patients to imagine their body image and well-being after mastectomy alone and after mastectomy with reconstruction. We will measure actual body image and well-being prior to surgery and at 18 months. We will compare predictions to outcomes and measure satisfaction with decisions. Hypothesis 2a: Patients will underestimate positive outcomes of mastectomy alone and overestimate positive outcomes of mastectomy with reconstruction. Hypothesis 2b: Larger mispredictions will be associated with lower satisfaction with decisions. Specific skills to be obtained include retention of a cohort of cancer survivors and evaluation of patient affective forecasting. Aim 3: To assess the effects of breast reconstruction on quality of life and body image and the potential modification of these effects by preference concordance. In the same cohort, we will measure quality of life and body image at baseline and at 6, 12, and 18 months. We will develop a model of post- mastectomy quality of life and body image, including preference concordance and decision making processes as covariates. The primary purpose of this aim is to obtain preliminary estimates of model parameters in anticipation of a future, larger study. Hypothesis 3a: Overall, patients who have mastectomy alone will have quality of life and body image similar to patients who have mastectomy with reconstruction. Hypothesis 3b: Patients whose treatment is preference concordant will have better quality of life and body image than patients whose treatment is preference discordant. Specific skills to be obtained include measurement of quality of life in cancer survivors and analysis of longitudinal observational data.